Voltage imaging of astrocyte-neuron interactions

Project summary
Astrocytes remove the excitatory neurotransmitter glutamate from the extracellular space following neuronal
activity via sodium-driven, voltage-dependent excitatory amino acid transporters (EAATs). Robust glutamate
uptake by EAATs ensures the temporal and spatial fidelity of glutamate signaling. Interestingly, we recently
found that neuronal activity rapidly (within milliseconds) and reversibly slows glutamate uptake in the adult
cerebral cortex. This slowing prolongs neuronal NMDA responses, consistent with prolonged extracellular
glutamate dynamics, and is highly dependent on the frequency and duration of stimulation. Additionally,
glutamate clearance can be modulated by neuronal activity with synapse specificity, even within a single
astrocyte. We believe this may have important consequences on neurotransmission, extrasynaptic receptor
activation, and synaptic plasticity. Based on this finding, we hypothesized that neuronal activity induces
microdomain-level changes in astrocyte membrane potential (Vm) that locally modulate EAAT function. GLT1 is
the predominant astrocytic EAAT in the adult forebrain, is abundantly expressed, and ensures that glutamate in
the extracellular space is rapidly sequestered by EAAT binding. Once bound to EAATs, the transport of
glutamate into the astrocyte is both sodium-driven and voltage-dependent. Under normal conditions, astrocytes
are hyperpolarized (-80 mV) due to their high permeability to potassium. However, neuronal activity increases
extracellular potassium, [K+]e, and astrocyte Vm is especially sensitive to [K+]e changes. Therefore, it stands to
reason that neuronal activity can alter EAAT function by depolarizing astrocytes. Changes in astrocytic Vm may
be especially relevant in fine astrocytic processes, where EAATs are concentrated, and where small intracellular
volumes may amplify changes in Vm, as compared to soma. We will also explore alternative mechanisms
including voltage-independent modulation of EAATs by increases in [K+]e. A major challenge to testing our
hypothesis, however, is an inability to monitor astrocyte Vm at distal processes due to low membrane resistance
and process morphology. Overcoming this challenge is important because astrocyte distal processes are the
site of synaptic interaction and EAATs localization. In order to detect distal changes in astrocyte Vm, we
developed an approach to image Vm in astrocyte processes using genetically-encoded voltage indicator (GEVI)
imaging. Utilizing astrocyte and neuron electrophysiological recording, optogenetic manipulation of astrocyte Vm,
and GEVI imaging of astrocyte membrane potential we have generated preliminary data that supports our
hypothesis that EAAT function can be modulated by activity-induced changes in astrocyte Vm.

Public health relevance
Project Narrative Neuronal activity modulates astrocyte glutamate uptake. We hypothesize that this occurs via voltage-dependent modulation of glutamate transporters in astrocyte distal processes. We will determine if modulating astrocyte Vm, independent of neuronal activity, alters glutamate uptake and utilize a genetically encoded voltage sensor to quantify Vm in astrocyte distal processes.